Stromal targeting to improve the efficacy of systemically administered drugs for pancreatic ductal adenocarcinomas

Project Summary
Only about 20% of pancreatic ductal adenocarcinoma (PDAC) patients are expected to survive one year from
diagnosis, with the overall 5-year survival rate reported at a devastatingly low 8%, which is the lowest 5-year
survival rate of all major cancers. A hallmark of PDAC is the dense extracellular stroma called the desmoplasia,
which can occupy up to 90% of the tumor volume. The desmoplasia acts as a physical barrier preventing drugs
from reaching the tumor cells. Additionally, the desmoplasia acts as a barrier that prevents immune cells from
infiltrating the tumor, limiting the efficacy of immunotherapies. Systemically administered stromal targeting
therapies have provided a promising route for reducing desmoplasia and allow both cells and drugs to enter the
tumor more readily. However, these agents have a wide range of off-target effects, which limits the dose that the
patient can receive. The overall goal of this proposal is to advance a local controlled release platform for
intratumoral delivery of hyaluronidase, allowing for locally elevated concentrations of the enzyme without
systemic involvement. Aim 1 will focus on the use of a multi-scale modeling approach to define the parameter
space of implant design needed to achieve a uniform distribution of hyaluronidase within excised human tumors.
Aim 2 is focused on the use of medical imaging to characterize the effects of stromal targeting agents on tumor
blood flow and drug accumulation. Aim 3 will characterize the effects that stromal targeting therapies have as
immunomodulatory agents for improved immune surveillance and evaluate treatment efficacy. The proposed
studies will establish a novel approach for targeting tumor desmoplasia, improving mass transport into the
tumors, and enhancing immune cell infiltration into the tumors.

Public health relevance
Project Narrative A hallmark of pancreatic ductal adenocarcinoma (PDAC) is a dense extracellular stroma that reduces mass transport and inhibits immune cell infiltration into the tumor. Systemically delivered stromal targeting therapies have shown promise at extending patients’ lives; however, the clinically effective doses result in potentially fatal side effects. Our goal is to advance a local drug delivery platform for intratumoral delivery of stromal targeting therapies to improve mass transport into the tumors, providing a window of opportunity to deliver systemic chemotherapy with greater effectiveness and improve immune cell infiltration into the tumors.